The Impact of Bundled Payments for Cardiopulmonary Disease on High-Risk Populations

Abstract
Our health care system is fragmented, which leads to suboptimal outcomes for high-risk populations with
chronic conditions, such as cardiopulmonary disease, combined with complex medical or social needs.
Bundled payments are an alternative payment model (APM) that incents efficiency by holding providers
accountable for costs and quality across an entire episode of care. The Center for Medicare and Medicaid
Innovation (CMMI) launched the Bundled Payments for Care Improvement (BPCI) initiative in 2013; a new
version of this program, BPCI-Advanced (BPCI-A), replaces BPCI in October 2018. Under both, participants
that meet cost targets keep the savings, while those that fail to do so pay Medicare back the difference. BPCI-
A has increased the financial incentives and added quality measures to further incentivize improvements.
Bundled payments provide strong incentives for providers to better-coordinate services and redesign care,
which could be very helpful for medically or socially high-risk older adults. These are populations for which
clinical innovations are sorely needed, and knowing which ones are being tried and appear to be working could
be very helpful in improving quality of care. On the other hand, bundled payments could induce providers to
avoid those patients or skimp on care, which could result in poor outcomes. Our overarching hypothesis is that
the financial incentives in BPCI had adverse consequences in high-risk cardiopulmonary patients, while the
enhanced incentives and use of quality measures in BPCI-A will reduce some of those consequences.
Quantifying the impact of BPCI-A on high-risk populations is critically important as Medicare and other payers
increasingly shift towards these and other alternative payment models. Examining a variety of medical and
surgical cardiopulmonary conditions that represent a range of acuity and complexity, our aims are to 1) Using
claims data, determine how BPCI and BPCI-A impact cardiopulmonary spending, access, and outcomes for
medically and socially high-risk populations; 2) Using a national survey, identify predictors of participation in
BPCI-A, and key approaches to care redesign; and 3) Combining claims and survey data, determine patient,
hospital, market, and strategic predictors of success under BPCI-A.
Our proposed work will provide timely information to inform annual updates to BPCI-A, and identify clinical
interventions that are strong candidates to improve cardiopulmonary care for all patients. Such work could help
to protect and optimize outcomes among high-risk populations. Absent these findings and the resulting policy
recommendations, BPCI-A could have unintended adverse consequences.

Public health relevance
Narrative Medicare launched the Bundled Payments for Care Improvement (BPCI) initiative in 2014, and its follow-on BPCI-Advanced in 2018, as experimental programs to test whether or not bundled payments were associated with lower costs of care. In this project, we seek to determine whether high-risk patients, defined as those who are poor, multimorbid, or frail, experienced any adverse effects of BPCI, and whether the program spurred hospitals to make meaningful improvements in care overall and for these groups in particular.